ELUCIDATION OF SUBSTRATES & SUBSTRATE SPECIFICITY OF PROTEIN PHOSPHATASE 2

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are using immunoffinity methods and mass spectrometry with the aim of determining how the various regulatory subunits alter PP2A specificity towards substrates.